EFFECTS OF NALTREXONE ON VOLUNTARY ALCOHOL CONSUMPTION

The goal of this project is to examine the effect of naltrexone, an opioid antagonist, on voluntary alcohol consumption in nontreatment seeking alcohol dependent volunteers using a laboratory self-administration paradigm. The specifics are:1) to determine whether subjects on naltrexone exhibit greater reductions in voluntary alcohol consumption than subjects on placebo; 2) to determine whether naltrexone modifies the subjective and neuorendocrine responses to alcohol; 3) to evaluate whether the subjective and neuroendocrine responses to alcohol predict further voluntary alcohol consumption; 4) to determine whether naltrexone differentially affects voluntary alcohol consumption and responses to alcohol in men and women; and 5) to determine if naltrexone alters anxiety in response to a stressor.